Actin regulation by cyclase-associated protein

Project Summary
Reorganization of the actin cytoskeleton supports many dynamic cell biological processes, such as cell
migration, cytokinesis, vesicle trafficking, and morphogenesis. Although actin spontaneously polymerizes and
depolymerizes by itself, the dynamic properties of actin need to be controlled by actin-regulatory proteins in
cells. Among many known actin-regulatory proteins, cyclase-associated protein (CAP) regulates multiple key
processes of actin dynamics. CAP is conserved among eukaryotes and has been known as an actin-monomer
binding protein for many years. However, recent studies have identified important functions of CAP, which are
critical to promote rapid actin turnover. CAP promotes disassembly of actin filaments from the pointed ends in
the presence of actin-depolymerizing factor (ADF)/cofilin. Spontaneous actin depolymerization from the pointed
ends is very slow and rate-limiting in actin filament turnover. The synergy between CAP and ADF/cofilin can
enhance actin depolymerization in vitro to a range that can explain rapid actin turnover in cells. However, the
precise mechanism by which CAP and ADF/cofilin induce actin depolymerization remains unclear, partly
because structural information of a CAP oligomer is limited. CAP oligomerizes under physiological conditions,
and oligomerization enhances its activity. We have recently obtained evidence that CAP is tetrameric, and our
structural model of the CAP tetramer allowed us to hypothesize a functional link between the tetrameric
configuration of CAP and processive actin depolymerizing activity. CAP also binds to the side of actin filaments
and synergizes with ADF/cofilin to promote filament severing. We hypothesize that this is due to the effect of
CAP on the helical structures of actin filaments, which then causes partial dissociation of ADF/cofilin from the
filaments. In addition to the in vitro studies, recent reports of human mutations in the CAP (CAP2) gene have
linked impairment of CAP to human diseases in the heart and skeletal muscle involving abnormalities in the
actin cytoskeletal organization. We will use the nematode Caenorhabditis elegans as a relevant model
organism to study roles of CAP in the assembly of sarcomeric actin filaments in muscle cells in vivo. We
proposes three aims: (1) to determine functional significance of CAP tetramerization for actin filament
disassembly, (2) to determine the effects of CAP on the helical structures of F-actin, and (3) to determine in
vivo roles of CAP in actin cytoskeletal integrity in the nematode Caenorhabditis elegans. We will employ a
combination of in vitro and in vivo approaches to gain new insight in the function of CAP in actin cytoskeletal
regulation.

Public health relevance
Project Narrative Dynamic reorganization of the actin cytoskeleton is essential for cell migration, cell division and morphogenesis. The basic regulatory mechanism of actin dynamics will be investigated by a combination of biochemical and genetic approaches.